IUSM Alzheimer's Disease Drug Discovery Center: PTC Software

Project Summary Overall: The strategic goal of the Indiana University School of Medicine (IUSM) Alzheimer’s Disease Drug Discovery (ADDD) Center is to integrate sophisticated capability for early drug discovery and contribute to a broader study of emerging Alzheimer’s Disease target hypotheses with the goal of generating new classes of potential therapeutics. The ADDD CENTER will establish itself as a strategic and operational partner for the NIA AMP-AD and MODEL-AD initiatives. By design, this will provide drug discovery capability to bridge the work in target discovery (AMP-AD) with newly discovered lead molecules characterized in AD animal models based on human pathology, genetics and translational biomarkers (MODEL-AD). To accomplish the mission of the ADDD CENTER, we have assembled a team of scientists from Indiana University, Purdue University, and the Indiana Clinical and Translational Sciences Institute (CTSI). This team has considerable expertise in Alzheimer’s disease biology, CNS pharmaceutical drug discovery and development, and scientific excellence in the core discovery technologies that will drive the ADDD CENTER’s contributions and deliverables. A key advantage and differentiated strength of the proposed ADDD CENTER is the primary scientific coordination and administration through IUSM. Specific Aims are: 1. Create a portfolio of characterized AD drug discovery targets representing novel intervention hypotheses that capitalizes on significant investments in basic research and emerging disease understanding. 2. Perform advanced pre-clinical target validation and enablement studies to prioritize the best opportunities for therapeutic discovery. 3. Create quality and well characterized Lead molecules for targets that meet milestone criteria and are opportunities for further translational investment. 4. Create a flexible data sharing platform to enable global researchers with data and Target Enablement Packages to expand on the work of the ADDD CENTER.

Public health relevance
PROJECT NARRATIVE FOR FUNDED PARENT AWARD (OVERALL) Alzheimer’s Disease is a major cause of death and disability in the United States and the National Alzheimer’s Project Act seeks to identify a treatment or prevention for Alzheimer’s Disease (AD) by the year 2025. In order to meet this ambitious goal, the Indiana University School of Medicine Alzheimer’s Disease Drug Discovery (ADDD) Center seeks to generate high quality lead molecules against novel, prioritized AD drug discovery targets emerging from the NIA/NIH AMP-AD initiative that are substrate for further optimization and translational study in patients. Importantly, the ADDD CENTER will share all data, methods and enabling science through an open access platform to benefit all AD investigators and associated research initiatives worldwide.